Targeting of Phosphoinositide Signaling in Migration, Invasion and Metastasis

DESCRIPTION (provided by applicant): Phosphatidylinositol-4,5-bisphosphate (PIP2) modulates the actin cytoskeleton, cell migration, invasion and signaling by binding effectors that regulate cytoskeletal dynamics and receptor trafficking. Yet, the mechanism of how PIP2 is generated to regulate these processes is poorly understood. Phosphatidylinositol phosphate kinases (PIPKs) that synthesize PIP2 specifically associate with PIP2 effectors. PIP2 then modulates the proteins and enzymes associated with the PIPK. PIPKIγ regulates growth factor stimulated directional cell migration, vesicular trafficking of adhesion receptors and invasion. Here, we show that PIPKIγ and PIP2 are required for establishment of cell polarity required for directional cell migration and invasion. In addition, we have discovered a novel signaling nexus that may explain how PIP2 mechanistically regulates many key effectors in adhesion, migration and invasion. Hypothesis: PIPKIγ controls key aspects of tumor cell migration and invasion by controlling the assembly of cytoskeletal components and the trafficking of adhesion receptors. Interactions between PIPKIγ, the exocyst and IQGAP1 function to integrate and specify the PIP2 generation and signaling required for growth factor stimulated directional cell migration, adhesion and invasion. In vivo the PIPKIg signaling nexus plays a key role in tumor cell intravasation and extravasation, processes required for tumor cell metastasis. Aim 1. The role of PIPKIγi2, the exocyst, and β1-integrin trafficking in directional cell migration will be investigated. Regulation of integrin trafficking by PIPKIγ and the exocyst will be defined with an emphasis on regulation by PIP2, the protein-protein interactions and cell polarity pathways, roles of small G-proteins, and specificity toward integrins. We will determine if a PIPKIγi2 interaction with talin acts as a tether for targeting the PIPKIγi2/β1-integrin/exocyst complex during directional cell migration. Aim 2. Define the mechanism for PIPKIγ and IQGAP1 regulation of directional migration. We will study the IQGAP1/PIPKIγ interaction and define how signals modulate this nexus. We will reveal the mechanism for PIPKIγ control of IQGAP1 association with membrane. We will determine if and how PIPKIγ modulates the association or activity of known IQGAP1 interactors, such as small G-proteins and the exocyst. Aim 3. Define the role of the PIPKIγ, IQGAP1 and exocyst in cell invasion. The role of PIPKIγ, the exocyst and IQGAP1 in formation of invadopodia will be revealed. An emphasis will be on targeting of key proteins required for invasion, such as IQGAP1, the exocyst, β1-integrin and MMPs to the invadopodia in a 3D matrix environment. Aim 4. Determine if PIPKIγ, the exocyst and IQGAP1 are required for extravasation and metastasis. Highly metastatic human breast cell lines will be engineered to over or under express PIPKIγ, IQGAP1 or Exo70. We will use a well-established mouse xenograft model to transplant engineered cells into the vasculature. The development and number of metastases will be used to quantify extravasation. PUBLIC HEALTH RELEVANCE: Cancer deaths occur because tumor cells migrate from the initial tumor site to other organs ultimately resulting in organ failure. This process predominatel occurs via the vasculature. In order for tumor cells to leave the primary tumor and enter the vasculature they must first alter their cellular phenotype. The goal of the proposed research is to identify the relevant enzymes and proteins that contribute to the phenotypic changes resulting in enhanced migration and invasion, so that clinical therapies can be developed to target these critical molecules.

Public health relevance
Cancer deaths occur because tumor cells migrate from the initial tumor site to other organs ultimately resulting in organ failure. This process predominatel occurs via the vasculature. In order for tumor cells to leave the primary tumor and enter the vasculature they must first alter their cellular phenotype. The goal of the proposed research is to identify the relevant enzymes and proteins that contribute to the phenotypic changes resulting in enhanced migration and invasion, so that clinical therapies can be developed to target these critical molecules.